PLATELET STRUCTURE AND KINETICS IN CYANOTIC CONGENITAL HEART DISEASE

This study will attempt to resolve questions regarding the etiology of the bleeding tendency and the thrombocytopenia in patients with cyanotic congenital heart disease (CCHD). A group of adult patients with CCHD, erythrocytosis and thrombocytopenia will be studied both before and after therapeutic phlebotomy, allowing each patient to serve as their own control.